Alaska FSS Maintaining Conformance with the Manufactured Food Regulatory Program Standards

Project Summary/Abstract
The proposed project is intended to continuously improve the efficiency and
effectiveness of Alaska's manufactured food regulatory program in its mission to
prevent and respond to foodborne illness outbreaks, by maintaining the program's
conformance with the manufactured food regulatory program standards (MFRPS.) In
addition to improved program performance, conformance with the MFRPS supports the
development of a nationally integrated food safety system and mutual reliance between
state manufactured food programs and FDA partners.
The program's newly-implemented information management system (IMS) is an
important tool in operationalizing the MFRPS and creating resilience in program
processes and procedures. Integration of standards-related activities such as quality
assurance audits, staff training and qualification documentation, and enforcement
review into the infrastructure of the IMS is a key component of MFRPS maintenance
efforts going forward. In addition, development of the IMS will simplify data exchange
between jurisdictions and improve evidence-based policy and program decision making,
which are also critical to maintaining a nationally integrated food safety system.
The proposed special project will examine the prevalence of best practices for Listeria
monocytogenes (LM) control in seafood processing facilities in Alaska, and correlate the
implementation of best practices with detection of LM in facilities and products. Data
from the study will be used to guide development of outreach materials and target
training to facilities where needed. Follow-up data and sample collections will assess
the effectiveness of the approach.
The Food Protection Task Force track will highlight and formalize the foodborne-illness-
prevention activities of two existing advisory committees, the Alaska Food Safety
Advisory Committee (AFSAC) and the Alaska Seafood Processing Advisory Council
(ASPAC), by creating opportunities for the committees to meet and focus on the best
approaches to reduce the occurrence of behaviors and situations that increase the risk
of foodborne outbreaks. The task force will bring industry, academia, and other
stakeholders together to work collaboratively to prevent foodborne illness in the state.

Public health relevance
Project Narrative This project serves to operationalize evidence-based best practices that improve, enhance, and sustain Alaska's capacity to prevent, detect, and respond to foodborne illnesses, and that also provide FDA with the foundation to pursue regulatory action based on inspections conducted in Alaska, by maintaining the Alaska Food Safety and Sanitation Program's conformance to the Manufactured Food Regulatory Program Standards. The special project track will assess the prevalence of best practices for Listeria monocytogenes (LM) control in seafood processing facilities in Alaska, examine the effectiveness of interventions on persistence and recurrence of LM, and guide development of outreach to facilities, with the goal of reducing the risk of LM infections. The Food Protection Task Force track will highlight and formalize the foodborne-illness- prevention activities of two existing advisory committees, the Alaska Food Safety Advisory Committee (AFSAC) and the Alaska Seafood Processing Advisory Council (ASPAC), by enhancing opportunities for the committees to meet and work collaboratively on the best approaches to prevent foodborne illness in the state.